Training Health Equity ScholaRs in InnoVation, PrEvention, and Social Impact (THRIVES) Fellowship Program

UC Berkeley Training HealthEquity ScholaRs in InnoVation, PrEvention, and Social Impact (UCB-THRIVES)
Fellowship Program
Despite extensive research documenting the existence of pervasive health inequities over the lifespan, there
is little research on preventive interventions to address these inequities. Thus, there is an urgent need to
train the next generation of public health professionals, especially those from historically marginalized
backgrounds, to be equipped with a comprehensive toolkit to confront these challenges. The UC Berkeley
Training HealthEquity ScholaRs in InnoVation, PrEvention, and Social Impact (UCB-THRIVES) T32
Fellowship Program proposes a collaboration between three graduate groups in the School of Public Health
(UCB-SPH): Epidemiology, Health Policy, and Environmental Health Sciences. The overarching objective is
to equip the upcoming generation of health equity scholars with the structural competency and
methodological acumen required to develop and evaluate multi-level, preventive interventions to address
health equity in partnership with marginalized communities. UCB-SPH is uniquely positioned to provide this
training due to its pioneering leadership in social epidemiology, community-engaged research, and
advanced statistical methods in causal inference. Furthermore, UCB-SPH demonstrates a profound
commitment to diversity, equity, inclusion, belonging, and justice, which will be leveraged to create a rich
training environment for pre-doctoral students. T32 trainees will receive innovative classroom training in
health equity, multi-level interventions, and methods in multi-level preventive interventions through
coursework and immersive research experiences, and they will be guided throughout by Individual
Development Plans. The core training domains will be supplemented with three salient cross-cutting themes
critical to achieving health equity: 1) community engagement, 2) anti-racism, and 3) social impact. The
UCB-THRIVES T32 Program has an excellent leadership team with Drs. Mujahid and Fernald serving as
Co-Directors, bringing a formidable track record of mentorship and complementary expertise to ensure the
academic and career success of the UCB-THRIVES trainees. The UCB-THRIVES T32 Fellowship Program
unites a cohort of 35 faculty mentors, including 65% female-identified faculty, 40% under-represented
minority faculty, and 31% at early career stages. Furthermore, the program faculty have a strong record of
grant funding, mentorship, and trainee success and will contribute their content area expertise and
opportunities to acquire practical research experience in community-based settings. An Advisory Committee
was thoughtfully selected to provide additional input and includes internationally recognized experts in
health equity, anti-racism, multi-level community-engaged preventive interventions, community-engaged
research, robust methodologies, and social impact. Ultimately, the UCB-THRIVES T32 Program will help
foster a new generation of scholars poised to pioneer innovative, preventive solutions to the most pressing
health equity challenges, all while embracing social justice as a guiding principle.

Public health relevance
Project Narrative The UC Berkeley Training Health Equity ScholaRs in InnoVation, PrEvention, and Social Impact (UCB-THRIVES) T32 Fellowship Program aims to equip emerging health equity scholars with the structural competency and methodological expertise essential for developing and evaluating multi-level, preventive interventions to address health inequities in collaboration with marginalized communities. The program will welcome 3 pre-doctoral students each year who receive comprehensive didactic training and immerse research experiences in health equity, multi-level preventive interventions, and rigorous methodological and statistical approaches. In addition to these foundational areas, three crucial cross-cutting themes will underpin the UCB- THRIVES T32 Program and be pivotal in driving sustainable progress in health equity: 1) community engagement, 2) anti-racism, and 3) social impact.